RhoFED CDSMC

PROJECT SUMMARY/ABSTRACT
The NIAID Clinical Data and Safety Management Center (CDSMC) is a consolidated clinical support service
center conceived to manage NIAID’s portfolio of clinical research in allergic diseases, asthma, autoimmune
disorders, and immune-mediated complications of transplant, continuing programs supported by Rho under
prior awards. Our vision is to advance NIAID’s history of successful clinical research by continuing our
successful collaboration in data management, safety, and specimen tracking with a focus on continuity while
embracing innovation. Over the last two decades, innovation has dramatically changed clinical trial operations,
with the technology revolution advancing trial data systems and advances in biology enabling research to halt
disease processes. The Rho team seeks to continue our support of NIAID’s work to deliver on this promise.
Rho has served as a clinical data, safety event, and biospecimen tracking center since its founding. Rho has
guided NIAID from the age of paper and FAX submissions through the introduction of computer data systems
and into the era of Software as a Service (“SaaS”) hosting of critical research systems. Over this time, Rho has
always focused on gradual evolution of systems to ensure that NIAID-supported research has access to the
current best practices in study management while avoiding the risks of too early adoption.
We propose to provide services by organizing the CDSMC into four cores: an Administrative Management
Core (AMC) that will be led by the Principal Investigator from a scientific perspective and the Program Director
from an operations perspective. The AMC will oversee the CDSMC; manage operational, quality, and
regulatory compliance reporting to NIAID; and coordinate DSMB support with NIAID and other functional work
areas. The Data Management Core (DMC) will provide strategic and operational support for data collection,
management, and processing; support the Rave EDC (Medidata, Inc. New York, NY); develop eCRFs and
build study databases; and manage data quality and the study data lifecycle. The Safety and
Pharmacovigilance Center (SPC) will receive, process, analyze, and report adverse events and provide
comprehensive pharmacovigilance support to NIAID-supported clinical trials. The SPC will provide support for
addressing safety and pharmacovigilance during study design and manage query generation and resolution,
narrative generation, summary reporting, and unblinding. The Specimen Tracking Core (STC) will inform
considerations of specimen handling and tracking during study design and will support tracking and reporting
during studies, leveraging our experience developing the specimen tracking strategy currently used in NIAID
DAIT studies. Based on our long history of supporting NIAID-funded clinical research and our experience
incorporating innovation into clinical research to deliver improvement and avoid risk, we believe we can
effectively support the achievement of NIAID’s research goals.

Public health relevance
PROJECT NARRATIVE The NIAID Clinical Data and Safety Management Center (CDSMC) is a consolidated clinical support service center conceived to manage NIAID’s portfolio of clinical research in allergic diseases, asthma, autoimmune disorders, and immune-mediated complications of transplant, continuing programs supported by Rho under prior awards. Our vision is to advance NIAID’s history of successful clinical research by continuing our successful collaboration in data management, safety, and specimen tracking with a focus on continuity while embracing innovation. Over the last two decades, innovation has dramatically changed clinical trial operations, with the technology revolution advancing trial data systems and advances in biology enabling research to halt disease processes, and the Rho team seeks to continue our support of NIAID’s work to deliver on this promise.